Data Management Core

CORE SUMMARY
The Data Management Core (DMC) will provide centralized data management and analysis services as well as
power calculations for all of the projects and cores in this proposal. This central assessment will facilitate the
comparison of results between projects, notably for RNA-Seq data, to compare and contrast allergen-specific T
cell phenotypes associated with different specificities and different clinical presentations. Further, the DMC will
be responsible for ensuring the timely submission of data and data analyses obtained under this award to the
Immune Epitope Database (IEDB) and the Immunology Database and Analysis Portal (ImmPort). For
centralized data management, we will utilize IMMUNOCAT, our in-house data management system. This
system is comprised of multiple interconnected databases, notably DoRAS for tracking donors and samples
along with clinical information. Here, we will extend DoRAS to ensure that all clinical information relevant to the
present proposal is captured. The database will be accessible through the internet and provide a consistent
basis to select samples and interpret results. All information in DoRAS will be coded, so that research projects
will not have access to sensitive information, allowing data to be freely shared. In terms of data analysis
services, we will provide a set of automated analysis pipelines that take the data generated by the research
projects and provide uniform and standardized analyses that will facilitate inter-project comparisons and
reproducibility. Pipelines for RNA-Seq data have already been fully implemented including user friendly web
reports for the generated results. To facilitate efficient data sharing with the IEDB, ImmPort and other
databases to make our datasets broadly available, we will take advantage of the fact that data generated in
this proposal will be captured in the IMMUNOCAT information management system. We will build dedicated
export modules that extract the relevant information for submission and translate it into the desired format. We
have extensive experience designing similar data management and export functionality from previous grants.